Path C The Maintenance & Expansion of the Produce Safety Program in Massachusetts

MASSACHUSETTS DEPARTMENT OF
AGRICULTURAL RESOURCES
Submission in Response to the Funding Opportunity Announcement (FOA) for
PAR-21-174
April 5, 2021 Revision 1.0
Project Summary
The Massachusetts Department of Agricultural Resources (MDAR), in partnership with the FDA, and
through funding provided under PAR-16-137, has identified and implemented program infrastructure
and services to support a robust and scalable produce safety program in Massachusetts. The Produce
Safety Inspection Program (PSIP) has been designed to provide education, technical support, and
inspectional services to further enhance an understanding and compliance with the Produce Safety Rule
(FSMA, CFR 21 Part 112) in Massachusetts. The proposed project will build upon this foundation to
expand and enhance the program area in support of a nationally integrated food safety system for
produce through the deployment of key milestones and objectives identified in PAR-21-174
requirements.

Public health relevance
MASSACHUSETTS DEPARTMENT OF AGRICULTURAL RESOURCES Submission in Response to the Funding Opportunity Announcement (FOA) for PAR-21-174 April 5, 2021 Revision 1.0 Project Narrative In response to the FOA for PAR-21-174, MDAR’s Produce Safety Inspection Program, will select and implement PATH C, as indicated in the FOA for PAR-21-174. MDAR’s PSIP will conduct produce safety inspections under authority established under M.G.L Chapter 128, section 124, adopting 21 CFR Part 112 in its entirety, and through regulations promulgated under 330 CMR 34:00